Bio-digital Rapid Alert to Identify Neuromorbidity

The silent development and progression of neurologic morbidity, or neuromorbidity, among hospitalized,
critically ill patients represents a newly recognized and emerging epidemic. This includes patients admitted to
intensive care units with primary neurologic diagnoses, those at increased risk based on their underlying
disease (e.g. neurotropic viral infections including COVID19), and those where the development of
neuromorbidity is occult and unexpected. Neuromorbidity associated with critical illness can be caused by
physiologic instability, biochemical derangements, side effects of medications, invasive mechanical support,
immobility, and/or other therapies used to prevent death. It spans the age spectrum from neonates to the
elderly, occurs across gender and race, and is underrecognized in patients with systemic illnesses (e.g. sepsis,
viral infections, and other inflammatory conditions) and critical organ failure (e.g. acute respiratory distress
syndrome, cancer, hepatic and renal failure). In the U.S. the incidence of neuromorbidity ranges from 5-47% in
critically ill children and adults, thus impacting hundreds of thousands of patients annually. Often
neuromorbidity evolves undetected until after clinical manifestations emerge and is irreversible. Neuromorbidity
can strike acutely, e.g. seizures, stroke, intracerebral hemorrhage, cerebral edema, and/or delirium, or in a
more protracted fashion, e.g. neuromuscular weakness and/or cognitive decline, and is often permanent,
endured throughout the remainder of a person’s lifetime. No standard clinical tool exists to identify patients at
risk for neuromorbidity or for real-time neurologic monitoring, in stark contrast to the heart, kidney, liver, and
many other organs.
To fill this gap and transform the way clinicians detect and monitor for evolving brain injury, we developed
a Bio-digital Rapid Alert to Identify Neuromorbidity (BRAIN) that continuously feeds electronic health record
(EHR) variables in 9 clinical domains (A through I) into proprietary informatics and machine learning platforms.
Prototype BRAIN A-I models are robust and predict clinician concern for neuromorbidity before clinical action is
taken. To link biological and digital signatures, we have defined a panel of serum biomarkers that can identify
time-documented neuromorbidity before clinical detection. Using a “Bayesian to Bedside” approach, we have
created a live data pipeline bridging the EHR and a dedicated host server, establishing the infrastructure
necessary to operationalize BRAIN A-I as an embedded predictive analytic and decision-driving support tool.
In this proposal we will test the hypothesis that digital signatures in the EHR coupled with brain-specific
biomarkers can rapidly detect neuromorbidity in critically ill children. Successful deployment of interoperable,
24/7 point-of-care neurologic monitoring for early detection of neuromorbidity would represent a breakthrough
for the clinical management of critically ill patients.

Public health relevance
The silent development and progression of neurologic morbidity, or neuromorbidity, among hospitalized, critically ill patients represents a newly recognized and emerging epidemic. Despite this, no standard clinical tool exists to identify patients at risk for neuromorbidity or for real-time neurologic monitoring, in stark contrast to the heart, kidney, liver, and many other organs. To fill this gap and transform the way clinicians detect and monitor for evolving brain injury, we propose to validate and deploy a bio-digital process for 24/7 point-of-care neurologic monitoring for early detection of neuromorbidity in critically ill patients.